PROTHROMBIN PRECURSORS IN BLOOD COAGULATION

Prothrombin, Factor X and Protein C are plasma zymogens that act at key points in the coagulation cascade. Their dependence on vitamin K for the synthesis of carboxylated zymogens has been exploited as the basis for most long term anticoagulant therapy. Yet the details of the intrahepatic events which occur in normal zymogen synthesis remain unclear. Only when the processing of these zymogens in the normal liver is understood can the alterations which occur during vitamin K deficiency, warfarin treatment, and severe liver disease be interpreted. The goal of this proposal is to gain insight into the postribosomal events which occur during synthesis of the vitamin K-dependent blood coagulation proteins. Prothrombin, Factor X and Protein C are synthesized in the liver initially as precursor molecules which then undergo several post-translational modifications including vitamin K-dependent formation of Gamma-carboxyglutamic acid. These investigations will concentrate on the order of intrahepatic processing and the role of each post-translational modification, especially vitamin K-dependent carboxylation, in influencing the subsequent steps in precursor modification. The effect of the vitamin K antagonist, sodium warfarin, a commonly used oral anticoagulant will be assessed by analyzing the precursors of Factor X, prothrombin and protein C isolated from the hepatic microsomes of normal and warfarin treated steers. The precursor forms of prothrombin, Factor X and protein C from normal bovine liver and from liver of steers treated with sodium will be purified and systematically characterized. Preliminary quantitation of crude microsomal precursors will be accomplished using specific radio-immunoassays for prothrombin, protein C and Factor X; preliminary characterization will be done by two dimensional electrophoresis followed by protein transfer to nitrocellulose and detection by antibody specific for prothrombin or Factor X or protein C. Precursor forms will be purified by immuno-affinity chromatography in conjunction with standard methods of protein purification. Once purified, the precursor forms will be characterized with regard to a) amino acid content including content of Gamma-carboxyglutamic acid, b) amino terminal sequence, c) carbohydrate content, d) molecular weight and e) isoelectric point. The Km's of the purified precursors and of proteolytic fragments of des-Gamma-carboxy zymogens will be determined using in vitro carboxylation.